CLINICAL RESEARCH CENTER FOR NEUROMUSCULAR DISEASE

The broad objective of this interdisciplinary project is to elucidate the pathogenesis of human neuromuscular diseases. The Center comprises 17 independent investigators in 13 laboratories. In many projects basic scientists and clinical investigators work together. Basic research includes the dynamics of muscle activation and contraction, calcium regulation in muscle, physiology of human muscle fibers, ultrastructure of muscle, development of muscle, muscle culture immunocytochemistry, glycoconjugates, structure and function of acetylcholine receptor. Clinical investigation includes study of muscular dystrophy, myasthenia gravis, malignant hyperthermia, disorders of glycogen and lipid metabolism, hexosaminidase deficiency, and peripheral neuropathy.